Dysregulated transcription processes in Ewing sarcoma

Abstract
Ewing sarcoma (EwS) is a pediatric and young adult cancer that is driven by the EWSR1-FLI1 translocation.
Despite decades of work, this cancer is still an enigma, with poorly understood biology and no targeted
treatments. Our recent work published in Nature demonstrated a previously overlooked consequence of
EWSR1-FLI1, that this fusion causes hyperphosphorylated RNA polymerase II (pRNAPII) due to loss of
EWSR1 inhibition of CDK7 and CDK9. We observed high levels of transcription, with high levels of R-loops
present in locations that R-loops normally (physiologically) occur. Based upon these findings, we began to
reconsider cellular phenotypes of EwS to identify the molecular basis of these phenotypes and ask whether
these changes provide a fundamental defect in all EwS. One phenotype that was previously identified in EwS
is that these cells display altered splicing profiles. In recent years there were several reports linking R-loops to
splicing, with splicing defects causing R-loop accumulation and R-loops being associated with sites of
alternative splicing. Further, it was reported that the splicing machinery inhibits DHX9 (aka RNA helicase A;
RHA) from causing accumulation of toxic R-loops. Also, of interest, is that EWSR1-FLI1 interacts with and
impairs DHX9 activity. By performing a genomic RNAi viability screen, we determined that EwS is acutely
sensitive to a loss of RNA processing capability. These collective observations led us to the hypothesis that
Ewing sarcoma is dependent upon RNA processing machinery to prevent accumulation of toxic R-
loops. If our hypothesis is correct, then it suggests that there may be a therapeutic opportunity to target
splicing components, converting the high levels of physiological R-loops in EwS into pathological R-loops to
drive toxic genomic instability. We propose to test our hypothesis with two Aims. In Aim 1, we will investigate
the mechanistic relationship between transcription levels, R-loops and splicing in EwS. For this we will
modulate splicing components by siRNA depletions, cDNA expression or use of pharmaceutical inhibitors,
examining transcription activity (Gro-Seq and uridine incorporation), splicing (reporters and RNA-Seq analysis)
and R-loops (DRIP-Seq). In Aim 2, we will examine whether EwS is particularly reliant on splicing components
or RNA:DNA helicases to block toxic conversion of R-loops and how targeting these processes impacts EwS
viability, DNA damage response and/or cell cycle progression. We will ask if these modulations effect EwS
cells at a particular time during cell cycle or stem cell state using single cell sequencing techniques. We will
also assess how these various components of R-loop biology interact with one another, with pRNAPII and with
R-loops in EwS. Finally, based upon these results, we will extend our findings to test efficacy of removing the
R-loop metabolizing program that EwS is most reliant upon as a means to inhibit EwS tumor growth. Overall,
this work should provide critical insight into the biology of Ewing sarcoma and provide new avenues for
treatment beyond the standard chemotherapeutics currently used.

Public health relevance
Narrative It is well established that Ewing sarcoma is driven by a fusion oncogene, EWSR1-FLI1, however the biology of this oncogene is poorly understood. In our prior work we identified that EWSR1-FLI1 dysregulates a fundamental process, transcription, causing an increase in R-loops. While R-loops serve normal functions, high levels of R-loops are considered deleterious and are often associated with genome instability and a loss of cellular fitness. The mechanism of how Ewing sarcoma is able to maintain high levels of R-loops without genomic instability is not known. If we can determine this mechanism, then we should be able to specifically target it as an alternate therapy for the treatment of Ewing sarcoma.